THE PRIMATE EMBRYO GENE EXPRESSION RESOURCE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Primate Embryo Gene Expression Resource (PREGER) permits the rapid and cost-effective study of gene expression in primate oocytes and preimplantation embryos using the rhesus monkey as the primary model organism. PREGER contains over 200 informative samples representing GV-stage oocytes, MIIstage oocytes, embryos at the 1-cell through hatched blastocyst stages, obtained using different combinations of in vitro or in vivo maturation, fertilization, and culture. The resource also contains stem cells and ovarian cells. This extensive and valuable sample set permits analyses of gene expression related to understanding basic primate embryology, as well as potential effects of clinical procedures on embryo quality using a primate model. Dot blots for expression analysis, cDNA libraries, probes, and other tools in PREGER can be distributed to other scientists, providing unprecedented opportunities for molecular studies in primate embryos. The libraries can be employed for a myriad of other purposes. The resource also includes a web site and online database. Most recently, the resource has incorporated an annual molecular embryology training course. The resource will facilitate basic research, and may support novel clinical approaches, e.g., in the evaluation of embryo quality. The proposed activities will at once maintain and expand the resource, produce new and fundamental basic information about primate embryos, and produce novel molecular approaches that may be useful in clinical practice.